Multi-polar stimulation module

COSMIIC Supplement Request – MPS Module Development
Abstract Summary
We propose to develop a “multi-polar stimulation” (MPS) module that is designed for
bipolar stimulation and stimulation of multi-polar nerve cuff electrodes. The MPS Module is an
upgraded module based on the platform COSMIIC System stimulator module. Each MPS can
drive any combination of four bipolar intramuscular and bipolar nerve cuff electrodes; or eight
monopolar intramuscular electrodes. Compared to the PG4, the MPS has expanded stimulation
channels (12 independent vs 4 monopolar) to accommodate additional electrode styles. Each
contact has an independent current source and allows full current steering between each
contact. The case of the MPS can also act as a return electrode, providing a total of 13
independent contacts. The MPS delivers a current-controlled, charge-balanced stimulus pulse
that is capable of delivering stimulation for any style of muscle-based electrodes (maximum
20mA pulse amplitude) as well as the stimulation resolution necessary for nerve cuff-based
electrodes (4μA resolution). The MPS includes impedance monitoring for each electrode.
Impedance monitoring allows identification of a broken electrode or lead disconnection, and
significantly enhances troubleshooting.

Public health relevance
COSMIIC Supplement Request - MPS Module Development Project Narrative The goal of this supplement is to develop a multi-polar stimulation module that can be incorporated into the COSMIIC Platform System.